Early Brain Development and Childhood Obesity

RELEVANCE TO PUBLIC HEALTH
Improved understanding of the potential underlying early influences on child obesity is an important first step
towards developing effective public health and educational policies. This study aims to examine the role of
infant early childhood brain development as a potential mediator linking genetic and pre and post-natal
environmental factors known to be associated with obesity, and child appetitive responses, appetitive-related
characteristics, and child weight trajectories and outcomes for the first time. With more than one third of US
children entering kindergarten currently overweight and at-risk for an array of preventable lifelong physical and
metal health conditions, this work addresses a pressing social, economic, and public health concern with
significant long-lasting affects.

Public health relevance
PROJECT NARRATIVE This research aims to address two important questions concerning the potential neurological and biobehavioral influences on pediatric obesity: 1. How are early brain growth patterns associated with appetitive-responses, appetite-relevant behaviors, and child weight? And 2. To what extent are they influenced by known genetic and pre and post-natal environmental factors known to be associated with obesity? This study aims to directly answer these questions and test a central hypothesis that genetic and early environmental conditions affect child eating behaviors and weight outcomes by altering patterns of brain development. To achieve this ambitious aim, we will combine longitudinal data from an existing infant study that includes rich neuroimaging measures, cognitive and behavioral data, genetic samples, growth measures and brief questionnaire data on pre and poat-natal environment factors; and a new targeted infant study that includes these same measures plus additional tailored behavioral measures of infant appetite, and more detailed questionnaire data on relevant pre and post-natal factors.